Administration and Management

Project Description The Administration Core will manage operations, develop and oversee finances, and maintain the website for the Washington University (WU) Biomedical Mass Spectrometry (MS) Resource. The Core will supervise and coordinate analytical workflows among Technological Research and Development projects (TRD 1-4), Driving Biological Projects (DBP), Collaboration & Service (C&S) activities, Dissemination & Training activities (D&T), and technology distribution activities. The Administration Core is the central point of integration for all technology, research, training and outreach activities. The Administration Core will efficiently monitor, coordinate, track technological research, development, advancement, and propagation, and update the MS Resource website; a point of access for submitting requests for technology, methods, and training, that increases global awareness/utilization of MS technologies. A goal of the Administration Core is to improve efficiencies for coordinating and tracking TRD, DBP, and all Core activities conducted in the Resource.

Public health relevance
Project Narrative-Public Health Relevance. The Washington University Biomedical Mass Spectrometry Resource has a longstanding history as an active and productive citizen in the NIH Biotechnology Research Resources community. We propose to extend our mission by advancing mass spectrometry technology, development, and research, applying these discoveries to answer critical biomedical research questions, and training the next generation of researchers, towards the ultimate goal of improving public health.